Determining Computational Principles Governing Neural Circuits Responsible for Feedback and Movement Control of D. Melanogaster Flight

PROJECT SUMMARY
A principle aim of the NINDS is to determine how motor control is successfully implemented by
the nervous system. Locomotion and balance are complex motor functions that are largely
controlled by complex microcircuits that reside outside the brain. Understanding how such
microcircuits function is critical to being able to treat diseases related to age, congenital disorders,
and trauma in which these circuits are impaired. This proposal will leverage advantages of a highly
tractable model system, the fruit fly (Drosophila melanogaster), to elucidate the computational
principles underlying the sensorimotor circuits that govern flight stabilization. Fruit flies are an
excellent model system for conducting such studies for several reasons. First, through a
collaborative project with the HHMI, the PI has helped develop ~220 transgenic fly lines targeting
sparse populations of neurons in the fly ventral nerve cord (VNC), which can be chronically
silenced, optogenetically activated, or optogenetically suppressed. Second, in experiments
pioneered by the PI, we showed that the reflexive responses of the fly to yaw, pitch, and roll
perturbations are described quantitatively by a proportional-integral controller—a control strategy
similar to a car’s cruise control or a sophisticated thermostat. Thus, the fly’s stabilization reflexes,
while complex, are well characterized. Consequently, there is an opportunity to systematically
interrogate neurons in the VNC and determine their effect on a sophisticated motor behavior.
Towards this end, in Aim 1 we will map the function of the motor system that actuates rapid flight
stabilization in flies. Specifically, we will chronically silence or transiently manipulate individual
motor neurons that innervate wing steering muscles and test control performance in free flight
and under rapid mechanical perturbations. In Aim 2 we will elucidate the functional role specific
mechanosensory neurons in the control reflex. Once again we will use chronic silencing or
transient manipulation of individual mechanosensory neurons and test control performance in free
flight and under rapid mechanical perturbations. Finally, in Aim 3 we will identify the neural
architecture connecting the mechanosensory inputs to the wing muscle outputs. Specifically, we
will use anterograde transsynaptic circuit tracing (trans-Tango) and ex-vivo functional imaging to
identify motor and interneurons that receive direct input from the genetically-identified
mechanosensory afferents. Together, these studies will enable us to determine with
unprecedented detail the organization and function of these microcircuits. In turn, this knowledge
will inform our understanding of design principles for sensorimotor circuits across animals.

Public health relevance
PROJECT NARRATIVE The successful moment-to-moment control of movement is contingent upon the function of complex neural microcircuits that reside outside the brain; understanding how these circuits function is critical to being able to treat age-related and developmental diseases in which these circuits are impaired. This proposal will leverage advantages of a highly tractable model system—the fruit fly—to determine how reflex circuits outside the brain enable successful movement and balance. Ultimately, elucidating the computational principles underlying these circuits will help inform our understanding of human circuits that must perform similar functions.